RENAL FUNCTIONAL RESERVE FOLLOWING RENAL TRANSPLANTATION

To expand on previous studies which imply that following a protein load meal renal functional reserve is deminished in the presence of cyclosporin A as compared to treatment with conventional immunotherapy (prednisone and azatheoprine.